Analysis of Glycomic Regulators in Melanoma Progression

PROJECT ABSTRACT
One of the hallmark features of cancer is the alteration of cellular glycosylation. The transition of localized
cancer to metastatic disease, which commonly leads to poor prognosis, critically features patent changes in
glycosylation. Metastatic cancer cells synthesize aberrant levels and variable structures of glycans compared
with their non-metastatic counterparts. Metastasis-associated glycans can modify cellular activities, such as
adhesion, invasion and proliferation, as well as encourage binding of pro-metastatic lectins. Hence,
metastasis-associated glycans and their related glycan-synthesizing enzymes offer attractive targets for
therapeutic interference of cancer progression. In accordance with this collaborative UO1 tumor glycomics
directive, we seek to leverage our complementary expertise and laboratory advances on analytics of cell
surface glycans and on tumor glycobiology to examine how modifications in glycan structure influence
malignant progression. Our guiding hypothesis is that acquisition of distinct metastasis-associated glycans
impacts malignant behavior and metastatic potential. In preliminary studies, gene set enrichment analysis
performed across (9) common human cancer types indicated that metastatic melanomas, above all, were
enriched for a `glycome' gene signature. Subsequent glycomic analysis indicated that metastatic melanoma
cells uniquely displayed a high level of i-linear poly-N-acetyllactosamines (polylacs), whereas normal human
melanocytes almost exclusively expressed I-branched polylacs. Further comparative glycome gene profiling
between normal melanocytes and metastatic melanoma cells identified suppressed levels of I-branching ß1,6
N-acetylglucosaminyltransferase (GCNT2) in metastatic melanoma cells that was significantly correlated with
melanoma progression. Enforced GCNT2 expression in human melanoma models strongly indicated that I-
branch/GCNT2 caused significant attenuation of melanoma growth in vivo and of cell signaling and
proliferation associated with insulin-like growth factor-1 receptor and ß1 integrins. I-branching GCNT2 activity
also inhibited binding of pro-melanoma metastasis lectin, galectin (Gal)-3. In this grant, we will leverage these
exciting melanoma glycomic data to investigate the role of i-linear/I-branch polylacs and GCNT2 as regulators
of metastatic melanoma behavior. The Specific Aims are: (1) To analyze function of I-branched glycans
and GCNT2 on melanoma cell activity and (2) To determine whether I-branch/GCNT2 expression
predicts melanoma progression. These Aims will be explored by a collaborative team of experts in tumor
glycobiology, glyco-analytics and melanoma pathology and include the use of clinically-relevant human and
mouse melanoma models and innovative histo-pathological, glyco-analytical and gene regulation systems.
Our far-reaching goal is to understand how melanomas metastasize - the causal step of melanoma lethality in
patients. Importantly, our findings will offer new insights into how glycomic regulators can be targeted for
therapeutic exploitation or used as biomarkers to predict melanoma metastasis and clinical outcome in patients.

Public health relevance
PROJECT NARRATIVE The overall objective of the grant is to understand how and why specific cell surface glycans promote melanoma progression. Our proposed studies will provide novel insights into how regulation of these malignant-associated glycans provides opportunities to therapeutically control melanoma aggressiveness and metastatic potential. Studies proposed here will help determine whether melanoma-specific glycans or their enzymatic regulators can be used to predict the potential for metastasis, thereby providing new methods for prognosticating clinical outcome.